Feasibility of study to delay myopia onset

7. Project Summary/Abstract
The prevalence of nearsightedness (myopia) is increasing worldwide, and so is the prevalence of high
myopia. Myopia, especially high myopia, is associated with sight-threatening complications such as myopic
maculopathy and retinal detachment. Slowing the progression of myopia may reduce the risk of sight-
threatening complications and improve a person’s quality of life. To date, all myopia control methods are
prescribed after the onset of the disease. A retrospective cohort study indicates that daily administration of low
concentration atropine may delay the onset of myopia, and a prospective cohort study of 928 myopic children
examined at age 11 estimated that for every year later myopia develops, a person is -0.86 less myopic or 2.86
times more likely to be highly myopic. Therefore, delaying the onset of myopia could lower the amount of
myopia experienced in adulthood and lower the risk of sight-threatening complications.
This proposal aims to establish the feasibility of conducting a randomized clinical trial to determine whether
0.05% atropine eye drops administered to children at risk of becoming myopic will delay the onset of myopia.
Before conducting the randomized clinical trial, we must determine the feasibility of finding 6-11 year old pre-
myopic children and establish the feasibility of enrolling them in a future randomized clinical trial to delay the
onset of myopia.
We will establish the feasibility of enrolling 6-11 year old children in a randomized clinical trial to determine
if we can delay the onset of myopia by comparing the time to myopia onset of children randomly assigned to
daily administration of 0.05% atropine or placebo. This will take place via two protocols:
1. We will measure non-cycloplegic retinoscopy on at least 3,500 children (at least 250 children at each of
14 clinic sites) to determine the proportion of children who would meet the non-cycloplegic retinoscopy
entry criteria.
2. We will invite 5 children per clinical site to participate in a two-week study to establish the feasibility of
enrolling pre-myopic children in a randomized clinical trial and measure compliance of eye drop
administration.
All of this information will help us determine how many children we must screen in order to enroll one child
in a future randomized clinical trial to delay the onset of myopia. We will also create a detailed manual of
procedures that will improve standardization of outcome measures, train examiners, and answer many
questions that may arise during the randomized clinical trial.

Public health relevance
8. Project Narrative Half of the world's population is estimated to be myopic by 2050, and the sight-threatening risks of myopia increase with higher myopia. This grant application helps plan a future randomized clinical trial to determine whether 0.05% atropine can delay the onset of myopia and ultimately make people less myopic as adults in order to preserve their sight and improve their quality of life.